White matter maturation and executive function advances in fetal alcohol exposure

DESCRIPTION (provided by applicant): Fetal alcohol spectrum disorders (FASDs) arise from the teratogenic effects of alcohol exposure, in utero, and are an important public health concern as they encompass one of the largest preventable causes of developmental disability. Specifically, deficits in cognitive function are the major contributor to long-lasting morbidity associated with these disorders, and are thought to relate to the broad spectrum of structural brain abnormalities that have also been observed in individuals with FASDs. Executive functioning is one cognitive domain that is particularly affected by fetal alcohol exposure, and includes an important set of cognitive control mechanisms that normally continue to develop through adolescence and help to modulate many other lower order cognitive and motor functions. These actions are thought to be meditated by activity in the frontal lobe, and functional deficits in these areas in children with FASDs may be related to abnormalities in white matter development that have also been observed in the context of fetal alcohol exposure. While frontal lobe white matter maturation also shows a protracted developmental trajectory, and has been related to advancements in executive functioning in typical development, a possible relationship between executive function deficits and white matter abnormalities in FASDs has not been investigated. This proposal aims to apply emerging diffusion magnetic resonance imaging (MRI) techniques, which allow for greater localization and an enhanced focus on developmental timing, to map white matter structural development and its relationship to executive functioning advancements in a sample of typically developing controls. These normative data will then be used as a benchmark for an investigation into the effects of prenatal alcohol exposure on executive function, white matter development, and their relationship. Most importantly, the results of these brain mapping efforts will be integrated into a broader classification framework to determine if indices of white matter development can help predict the level of executive function deficit among individuals with FASDs. This work may eventually lead to a better characterization of the precise functional deficits that affect each patient, and facilitate the application of the most appropriate clinical interventions for each individual at an earlier time point than what is allowed by neuropsychological testing alone. PUBLIC HEALTH RELEVANCE: Fetal alcohol exposure is one of the largest preventable sources of developmental disability. By mapping white matter maturation and its relationship to executive functioning advances in both typical development and fetal alcohol spectrum disorders (FASDs), we may be able to develop useful predictive models that can aid in the application of personalized clinical interventions tailored to the specific functional deficits of each individual child.

Public health relevance
Project Narrative Fetal alcohol exposure is one of the largest preventable sources of developmental disability. By mapping white matter maturation and its relationship to executive functioning advances in both typical development and fetal alcohol spectrum disorders (FASDs), we may be able to develop useful predictive models that can aid in the application of personalized clinical interventions tailored to the specific functional deficits of each individual child.